Amplify Gait to Improve Locomotor Engagement in Spinal Cord Injury (AGILE SCI Trial)

Background: Among ambulatory individuals with incomplete spinal cord injury (iSCI), residual balance deficits
are common and are a primary factor limiting participation in walking activities. There is broad recognition that
effective evidence-based interventions are needed to enhance dynamic balance following iSCI. However,
improving dynamic balance after iSCI has proven to be very challenging. Experimental interventions that amplify
self-generated movements (e.g. error augmentation) may accelerate motor learning by intensifying sensory-
motor feedback and facilitating exploration of alternative motor control strategies. These features may be
beneficial for retraining dynamic balance after iSCI. We have developed a cable-driven robot to create a
movement amplification environment during treadmill walking by applying a continuous viscous force field to the
pelvis that is proportional in magnitude to a participant’s real-time COM velocity. Our purpose is to investigate if
locomotor training performed in a movement amplification environment can effectively improve dynamic balance
and increase participation in walking activities of individuals with iSCI.
Specific Aims: Aim 1: To evaluate if locomotor training performed in a movement amplification environment is
effective for improving dynamic balance of individuals with iSCI.
Our pilot data found that following locomotor training performed in a movement amplification environment
three individuals with iSCI each improved dynamic balance by more than 30%. These improvements were
accompanied by faster over ground walking speeds and improved reactive balance. Thus, we hypothesize that
improvements in dynamic balance during walking will be greater when locomotor training is performed in a
movement amplification environment when compared to locomotor training performed in a traditional treadmill
environment.
Aim 2: To evaluate the impact of locomotor training performed in either a movement amplification environment
or in a traditional treadmill environment on participation in walking activities.
Based on evidence identifying a strong relationship between balance and steps per day in ambulatory
individuals with iSCI, we hypothesize that training in the movement amplification environment will positively
impact dynamic balance, and in turn increase participating in walking activities.
Approach: We will conduct a two-arm parallel-assignment intervention. We will enroll 36 ambulatory participants
with chronic motor incomplete spinal cord injury. Participants will be randomized into either a Control group
receiving locomotor training or an Experimental group receiving locomotor training performed in a movement
amplification environment. All participants will receive 20 training sessions. We will assess changes in dynamic
balance using measures that span the International Classification of Functioning, Disability and Health (ICF)
framework including; 1) clinical outcome measures of gait, balance, and quality of life, 2) biomechanical
assessments of the capacity to control COM motion during walking, and 3) data collected from activity monitors
to quantify changes in participation in walking activities as evaluated by number of steps taken per day.
Impact: Training dynamic balance of individuals with iSCI by amplifying their own self-generated center of mass
motion during walking is a radical departure from current practice and may create effective new clinical strategies
for addressing balance impairments of individuals with iSCI. Successful outcomes from the proposed trial would
motivate development of clinically-feasible tools to first replicate and then to evaluate the movement amplification
environment within the VA’s clinical care settings. Knowledge gained from this study will expand our
understanding of how individuals with iSCI learn dynamic balance and how targeted dynamic balance training
impacts participation in walking activities.

Public health relevance
Spinal cord injury (SCI) affects ~42,000 Veterans. The VA provides the single largest network of SCI care in the nation. The lifetime financial burden of SCI can exceed $3 million. A major cost of SCI is impaired mobility. Limited mobility contributes to decreased ability to work, increased care requirements, secondary injury, depression, bone mineral density loss, diabetes, and decreased cardiovascular health. Among ambulatory individuals with iSCI, residual balance deficits are common and are strongly correlated with both functional walking ability and participation in walking activities. The development of effective rehabilitation tools to improve dynamic balance would substantially improve quality of life for Veterans living with iSCI. Improving mobility through interventions that enhance dynamic balance would positively impact health, independence, and the ability to integrate into social, intellectual, and occupational environments.